GABA and NPY signaling interact to shape inhibition in the auditory tectothalamic pathway

Inhibition critically shapes auditory signal processing, impacting nearly every aspect of hearing. In the inferior
colliculus (IC), inhibition shapes how neurons respond to auditory cues that are essential for speech and
vocalization processing, including frequency tuning curves and directional selectivity for frequency modulated
(FM) sweeps. In addition, diminished synaptic inhibition is a critical feature in age-related hearing loss. The IC is
considered the hub of the central auditory pathway, and despite the crucial role of inhibition in the IC, the cellular
mechanisms underlying GABAergic inhibition remain largely unknown. This gap in our understanding exists
because it has been proven difficult to identify distinct GABAergic neuron types in the IC. We recently overcame
this problem by identifying Neuropeptide Y (NPY) expression as a marker for a novel class of inhibitory principal
neurons in the IC. NPY neurons are GABAergic, have a stellate morphology and project to the auditory thalamus
(MG). In addition, we found that NPY signaling dampens the excitability of a large family of IC glutamatergic
neurons that express the NPY Y1 receptor (Y1R). In this proposal, we will investigate how the co-release of NPY
and GABA affects auditory processing in vivo. The overall objective of this research is to determine how NPY
and GABA signaling from a defined class of IC GABAergic neurons influence Y1R neurons to shape frequency
tuning and FM sweep direction selectivity in the auditory tectothalamic pathway. We will further determine
whether augmenting NPY signaling improves features of auditory processing in the IC and MG that are disrupted
in a mouse model of aging. To pursue these objectives, we will use in vitro and in vivo electrophysiology,
combined with pharmacology, chemogenetics and optogenetics.
Aim 1. We will perform in vivo recordings in the IC-MG pathway while using chemogenetics and optogenetics to
modulate NPY and GABAergic signaling. This aim will determine how NPY signaling shapes the tonal receptive
fields and FM sweep direction selectivity of neurons in the IC and MG.
In Aim 2, we will use electrophysiology and viral tract tracing to investigate how NPY and Y1R neurons interact
to shape postsynaptic activity in the MG. We will further determine how excitatory-inhibitory interactions in this
circuit are affected in a mouse model of aging. This research will provide a mechanistic understanding of how a
distinct subtype of GABAergic neuron interacts with neuropeptide signaling in the IC to shape auditory
computations in the tectothalamic pathway.

Public health relevance
Public Healthy Relevance Inhibitory circuits in the auditory tectothalamic pathway critically shape speech and vocalization processing, sound localization and other neural computations that are crucial for hearing. This proposal aims to determine how GABA and NPY signaling from a molecularly defined class of inferior colliculus (IC) inhibitory neurons shapes sound processing in the IC and medial geniculate (MG). The results of this proposal will provide important new information about how a defined inhibitory neural circuit contributes to the ability of IC and MG neurons to produce selective responses to communication sounds. In addition, the proposed research will establish whether manipulations of NPY signaling can improve auditory computations in a mouse model of age-related hearing loss. Together, these results will provide a mechanistic foundation for the rational development of therapies that manipulate inhibitory signaling to improve hearing for the hearing impaired.